DJ-1 and hexokinases

We have been interested in the relationship between oxidative stress and DJ-1, a rare cause of recessive Parkinson's disease, for several years and have focussed the relationship between oxidative stress and mitochondrial localization. We have been focussed on developing new resources for these experiments including recent reporting of IPSC cell lines from rare DJ-1 case and an engineered line with the same mutation and isogenic control. To date, we have characterized the general ability of these lines to support differentiation into target cell types.